Deciphering pathogenesis and therapeutic vulnerabilities in germline RUNX1 mutated AML

PROJECT SUMMARY
RUNX1 mutations have been identified in 10-20% of acute myeloid leukemia (AML) patients with up to a third
being reported as germline, characterized by chemoresistance and poor prognosis. Natural history and genomic
studies suggest that germline RUNX1 mutated patients typically present with three disease stages: 1) an initially
indolent stage of familial platelet disorders (FPD) harboring monoallelic germline RUNX1 mutation, 2) an
insidious pre-leukemic stage carrying biallelic RUNX1 mutations and 3) an end stage of fulminant, leukemic
transformation (FPD-AML) with acquisition of additional somatic mutations often involving signaling effectors
(most commonly FLT3). Dissecting how germline RUNX1 mutations cooperate with these somatic events to drive
leukemic transformation (which remains unknown) will shed new light on AML pathogenesis and therapies.
Faithful preclinical models including genetically engineered mouse models and patient derived xenografts, critical
for studying leukemogenesis and therapeutic development, are largely lacking for FPD-AML. We have recently
developed a model of FPD to AML progression by temporally introducing somatic events in mice carrying
Runx1R188Q/Flox;Flt3ITD-frt/+;RosaFlpoER;Mx-Cre alleles in which sequential inactivation of Runx1 followed by Flt3ITD
activation recapitulated the genetic events and disease progression in FPD patients. Furthermore, biallelic but
not monoallelic Runx1 mutations are critical for transformation in this model. We observed that multipotent
progenitors (MPPs) in this context upregulate self-renewal transcriptional programs and serially propagate
leukemia upon transplant. We further employed CRISPR dropout screens and identified the histone H3 lysine 4
(H3K4) methyltransferases Mll4 and Mll5 as candidate dependencies in Runx1-mutant cells. Lastly, Mll5 mRNA
expression and H3K4me3 levels are increased in biallelic Runx1 mutated cells. Thus, we hypothesize that
biallelic Runx1 mutations enable an H3K4me3 driven epigenetic and transcriptional cell state in MPPs through
the activity of Mll4 and/or Mll5, which further cooperates with subsequent oncogenic events (e.g. Flt3ITD) to
activate self-renewal programs resulting in leukemic transformation. We will determine the mechanisms by which
mutant Runx1 alone and in cooperation with Flt3-ITD drives leukemic transformation in FPD and interrogate
therapeutic efficacy of inhibiting Mll4/Mll5 and its effector H3K4me3 in FPD-AML. Completion of these studies
will: 1) provide greater insights into the epigenetic and transcriptional mechanism of leukemic transformation in
FPD; 2) delineate the role of RUNX1 mutations in FPD-AML; 3) inform whether strategies targeting mutant
RUNX1 and epigenetic regulators (MLL4/MLL5/H3K4me3)) may have therapeutic relevance in preventing or
reversing myeloid transformation, thus paving the road to developing novel clinical-grade therapies. The gained
knowledge may be extrapolated to other types of AML and RUNX1-mutated malignancies.

Public health relevance
PROJECT NARRATIVE RUNX1 mutations are frequently detected in acute myeloid leukemia (AML) patients with up to a third being reported as germline. Germline RUNX1 mutations lead to familial platelet disorder (FPD), which is associated with high risks for leukemic transformation. Our work aims to use novel murine and human FPD models to understand the molecular mechanisms of leukemic transformation and identify novel therapies in patients with germline RUNX1 mutations.